Role of Langerhans Cell-Sensory Neuron Interactions in Wound Healing and Nociception After Burn Injury

PROJECT SUMMARY
Wound care is essential for patients with burn injury. Wound healing is commonly linked with itch
and pain. After burn injury, monocyte-derived Langerhans cells (LCs) are recruited from the bone marrow
to the epidermis and may play a role in wound healing. Additionally, itch and pain are mediated by the free
nerve endings of nociceptive sensory neurons, which are often located close to resident LCs in the
epidermis. However, our understanding of the role of LCs in modulating wound healing, itch, and pain is
particularly limited because approaches to selectively manipulate the activity of LCs have not been
established. Here, we hypothesize that distinct subsets of LCs mediate wound healing, itch, and pain. To
test this hypothesis, we have successfully applied optogenetics to directly control the activity of LCs by
establishing a mouse line that selectively expresses light-sensitive cation channels (ChR2) in LCs. We
have also successfully applied chemogenetics to directly control the activity of LCs by establishing a
mouse line that selectively expresses Gq- or Gi-biased Designer Receptors Exclusively Activated by
Designer Drugs (Gq- or Gi-DREADD) in LCs. The long-term goal of this application is to advance our
understanding of the molecular mechanisms behind wound healing, itch, and pain regulated by LC-
sensory neuron interaction. Aim 1 will determine the role of LC-sensory neuron interaction in wound
healing using hematopoietic chimeras in which monocyte-derived LCs selectively express Gq- or Gi-
DREADD and transgenic mice in which sensory neurons selectively express Gq- or Gi-DREADD. Aim 2
will determine the contribution of LCs to postburn itch and pain using hematopoietic chimeras in which
resident LCs selectively express ChR2 or Gi-DREADD, single-cell RNAseq, and in vitro calcium imaging
from LCs. This proposal will help us to understand completely new roles for LCs and how they may
regulate wound healing and wound-related itch and pain. The successful completion of this proposal
would provide a unique approach to treating wound healing, wound-related itch, and pain by targeting LCs.

Public health relevance
PROJECT NARRATIVE Wound healing and wound-related itch and pain are a significant clinical problem that is poorly treated. This project will investigate how interactions between Langerhans cells and sensory neurons affect wound healing, itch, and pain and thereby provide a novel therapeutic strategy. The information gained from this project will provide new insight into Langerhans cell functions.